PILOT STUDY OF DOSE RESPONSE OF INHALED BECLOMETHASONE

The purpose of this research is to determine if giving a larger dose of an inhaled asthma drug will prevent asthma due to allergies. The tests in this study will be evaluated for efficacy.